Appalachian Training Program in Occupational Health and Safety

Appalachian Training Program in Occupational Health and Safety
Project Summary
The Appalachian Training Program in Occupational Health and Safety at West Virginia
University (WVU) serves a critical need to supply qualified occupational health and safety
professionals for our state and region. Our specific goal is a practical one: to train professionals
who understand hazardous workplaces and who are prepared to serve in a “front-line” capacity
to prevent, mitigate, and manage workplace injuries and disease in a rural context. We
emphasize the recruitment and training of graduates who will be committed to remain within the
Appalachian region. The Appalachian Training Program in Occupational Health and Safety
provides Master's level training in Industrial Hygiene (IH), both Master's and Doctoral-level
programs in Occupational Safety and Health Engineering (OSHE), and an Occupational
Medicine Residency (OMR) for physicians. Although this is not an Education and Research
Center (ERC), it is one of only three NIOSH-supported Training Project Grants to offer multiple
programs. The OMR has been supported by NIOSH since 1988, the IH program since 1980
and the OSHE program since 2005.
It is difficult to overstate the importance of these programs to Appalachia, defined by the
Appalachian Regional Commission as a 205,000 square-mile area with approximately 25 million
people extending from southern New York to northern Mississippi. This is the only OMR in the
entire region, and there are only two other NIOSH-supported programs providing training in IH
and OSHE. Not only do these programs serve critical regional needs for qualified occupational
health and safety professionals, but this grant helps connect programs based within the
Benjamin M. Statler College of Engineering and Mineral Resources to those of the Robert C.
Byrd Health Sciences Center (HSC) and form the nucleus around which larger activities are
built, such as broader educational outreach, research, clinical service, workplace evaluation and
control efforts, and national/international faculty recruitment and retention. All three programs
benefit not only from the resources of a large, land-grant university but a close relationship with
all three Divisions of NIOSH-Morgantown, currently the only such facility in the country located
on a university campus and adjacent to the HSC.

Public health relevance
Appalachian Training Program in Occupational Health and Safety Project Narrative Appalachia is arguably one of the most underserved regions in the country, with an unacceptably high burden of occupational disease and injuries. The Occupational Medicine, Industrial Hygiene, and Occupational Safety and Health Engineering programs produce skilled professionals who understand the workplaces of this rural area, diagnose and treat injured workers, focus upon use of engineering to measure and identify hazards, understand failure modes and effects to engineer out such hazards and who are prepared for and dedicated to the public health aspects of mitigation and prevention in the region. This is the only NIOSH- supported Training Project Grant in Occupational Medicine and one of two in Occupational Safety and Industrial Hygiene located in the entire Appalachian region, comprising portions of 14 states.